Systematic understanding of RNA-centric mechanisms of gene regulation in chromatin

A major focus of modern RNA research is to understand its regulatory roles beyond its coding potential. In
chromatin, diverse types of RNAs are increasingly recognized as regulators of gene expression programs. For
example, many short or long noncoding RNAs (ncRNAs) are involved with histone modifications that are
important for epigenetic gene regulation. Even nascent RNAs, conventionally viewed as intermediates between
genes and proteins, are acknowledged for their regulatory potential as they can affect chromatin-associated
proteins (CAPs)’ activities. However, understanding the underlying molecular mechanisms of regulatory RNAs
remains challenging. This difficulty arises from RNA's inherent biochemical flexibility, where not only its primary
sequence but also its secondary and tertiary structures influence function. Additionally, regulatory RNAs often
exhibit evolutionary divergences in a sequence level, complicating the investigation.
My laboratory is interested in RNA-mediated gene regulation in chromatin. We use interdisciplinary
approaches spanning genetics, computational genomics, and high-throughput biochemical assays to understand
the mechanisms of regulatory RNAs in chromatin. Our current projects aim to develop a systematic approach to
detecting regulatory RNAs and their functional RNA motifs, based on RNA-protein interactions. Specifically, we
will first test whether RNA regulates CAP’s genomic occupancies. Second, we will use RNA-editing-based
approach to detect RNAs interacting with a CAP. Third, we will develop a high-throughput assay and
computational methods to detect functional RNA elements binding to a CAP, based on RNA-centric deep
mutational approach. Lastly, we will check whether functional RNA elements are conserved by considering both
sequence and secondary structure. We will apply our approach to a histone modifier, LSD1/KDM1a, and its
interaction with RNA, including a long ncRNA, HOTAIR.
Our results will provide a deep understanding of LSD1-RNA interactions, as well as present a
generalizable approach to study how RNA mediates regulatory roles in chromatin. In addition, as LSD1 is a drug
target for many diseases such as cancer and psychiatric disorders, our results will offer insights into the
development of RNA-based therapeutic strategies. In parallel to scientific contributions in the field of RNA
genomics, we will devote ourselves to motivating and training next-generation scientists to develop
interdisciplinary skills and minds to tackle important questions in biology. As biology undergoes a transformative
integration with data science and artificial intelligence methodologies, it is vital to use both experimental and
computational techniques and interpret them appropriately. Throughout the project, we will provide
interdisciplinary training opportunities to trainees.

Public health relevance
Project Narrative RNA in chromatin has been increasingly appreciated as a critical regulatory axis in gene expression. In this proposal, we will investigate a systematic approach to uncover RNA-centric mechanisms of gene regulation in chromatin with a focus on RNA’s interaction with chromatin-associated proteins such as histone modifiers. Our results will provide an RNA-centric high-throughput assay and computational methods to study regulatory RNAs in chromatin, contributing to the general understanding of RNA-mediated gene regulation in disease and development.